Mental Health in Autistic Adults: An RDoC Approach

Administrative Core Abstract
To operate a cohesive, coordinated, and effective Program Project, central coordination is required. The Administrative Core provides the organizational structure and supports integration of the Cores and Research Projects. The Administrative Core is led by Dr. Mazefsky, Program Director, a clinical psychologist and Professor who has specialized in emotion dysregulation and mental health in autism across the lifespan for more than 15 years. She is supported by Administrative Core Co-I’s, Dr. Brent, UPMC Endowed Chair of Suicide Studies, Dr. Iyengar, Professor and Chair of Statistics, Dr. Karim, a Bioengineer and K-awardee, and Ms. Morénike Giwa Onaiwu an autistic educator, parent to autistic and non-autistic children, and global advocate who is American-born to immigrant parents. The Administrative Core includes two boards: 1) the Steering Committee, which includes all Project and Core Investigators and Leads, and 2) the External Partners Board and included scientists with a wide array of expertise, autistic adults, parents, and advocacy group leaders. The goals of the Administrative Core are to: 1) Supervise of all Center administrative functions (scheduling meetings, setting and evaluating milestones, data requests, resolving conflict and ensuring open communication among Center investigators and staff), 2) Oversee the Center budget, including expenditures and allocation of funds according to Center priorities and distribution of Core resources, 3) Monitor compliance with Federal and University policies and procedures, such as NIH Public Access Policy, Data Sharing Plan, Conflict of Interest, and Human Subjects Research Protection, 4) Develop and provide oversight of the Center Database, 5) Create databases that integrate different data streams for integrative analyses and other data requests, 6) Submit data to NIMH Data Archive twice per year, 7) Review requests for data and new projects, 8) Provide statistical oversight regarding integrative analyses; and 9) Organize the External Partners Board Meetings.